Pediatric Mild Traumatic Brain Injury and the ABCD Study: A Prospective Behavioral, Psychiatric, Neurocognitive, Imaging, and Genetic Investigation

Mild traumatic brain injury (mTBI) is a major public health problem in the United States. Data from the
Adolescent Brain Cognitive Development (ABCD) study afford our team an opportunity to significantly
advance the study of mTBI-associated behavioral, psychiatric, and neurocognitive problems which are
very controversial. We shall analyze biopsychosocial data generated since 2016 from this ten-year prospective
longitudinal 21-site national study of an enrolled cohort of over 11,000 nine/ten-year old children who have
been subsequently evaluated annually. The study design permits a rare analysis of predictive factors and
mechanisms of post-injury behavioral, psychiatric, and neurocognitive outcomes by examining child and
family variables collected pre-injury and post-injury in the 237 children who have so far suffered a mTBI in
the years subsequent to enrollment. The mTBI group will be compared with two groups of children 1) with a
post-enrollment accidental bone fracture (orthopedic injury; OI); and 2) a lifetime “no injury” (NI) group.
Additional children who have had a mTBI will be identified and will be compared with OI and NI controls in the
first month of the study, and at the end of year 2 and middle of year 4 of the five-year study.
There are three unique aspects of the proposed study. 1) Pre-injury and post-injury sequential
structural and functional neuroimaging data facilitate predictive and mediation analyses of behavioral,
psychiatric, and neurocognitive outcomes using individual pre- versus post-injury changes and group
differences in brain maturation trajectories. 2) Genetic data permit predictive and moderation analyses of
outcomes using a novel systems biology approach not based on candidate genes. 3) The proposed study
evaluates multiple neurocognitive domains before and after mTBI.
The study will examine 3 major hypotheses: (1) Change in behavioral measures and changes in
neurocognitive function will be of greater magnitude, and new-onset psychiatric disorders will occur at a
significantly higher rate, in children with mTBI compared with children with OI and NI. (2) Behavioral changes,
new-onset psychiatric disorders, and neurocognitive function changes in children will be predicted by pre-injury
child variables (sex, adaptive function, academic and cognitive function, lifetime psychiatric disorders,
behavioral ratings, brain structure and functional MRI measures, and genetic factors), and pre-injury family
variables (socioeconomic status, family function, family psychiatric history) in children with mTBI, OI, and NI.
(3) The occurrence and pattern of behavioral changes, new-onset psychiatric disorders, and neurocognitive
function changes will be mediated by child brain variables (trajectory of brain maturation), post-injury family
variables (functioning and stressors), and injury variables (age at injury, time-since-injury, severity, presence of
a brain lesion, and extent of diffuse axonal injury) and moderated by child gene structure (genetic factors), in
children with mTBI, OI, and NI.

Public health relevance
Pediatric mild traumatic brain injury (mTBI) is a major public health problem in the United States. This study permits a pre-injury and post-injury assessment of biopsychosocial predictors and mechanisms of the behavioral, psychiatric, and neurocognitive impact of mTBI, minimizing error and bias that may occur with post- injury retrospective reports of pre-injury status. This study will foster more accurate prediction, earlier identification and improved treatment of children with behavioral, psychiatric, and neurocognitive complications related to mTBI.